Investigating the Impact of Selective Vagal Neuromodulation on Heart Failure Indices

Project Summary/Abstract
With a five-year mortality rate of over 50% and an estimated 70 billion dollar annual cost burden projected
for the United States by 2030, improved treatment modalities are needed to advance treatments for heart
failure. Because the heart is heavily regulated by autonomic nervous system inputs and neuronal circuitry
within the heart, the investigation of neuromodulation strategies is of great interest. Parasympathetic
pathways of the vagus nerve balance hyperactivity associated with sympathetic overdrive, and infer
cardioprotective effects by preventing hypertrophy of cardiomyocytes, reducing structural remodeling in the
heart, and down-regulating inflammatory mediators. However, vagus nerve stimulation (VNS) in clinical trial
heart failure patients has not translated to improvements in primary metrics of cardiac remodeling, functional
output, and rate of death, although quality of life metrics were improved in multiple studies. Due to the lack
of translation from pre-clinical data to clinical outcomes, better understanding of the neural interface is
needed.
The current project will study the impact of selective vagal neuromodulation in a heart failure model on left
ventricle structure & function indices as well as inflammatory mediators in the myocardium. The study will
employ optical neuromodulation of the vagus nerve which enables axonal recruitment profiles not feasible
with electrical VNS. Selective activation of cholinergic (efferent) and glutamatergic (afferent) neuronal
subsets will be targeted to isolate the impact of these vagal components. Micro-resolution, 3D-printed
silicone nerve cuffs will be leveraged in rodent models of heart failure to characterize the effect of a chronic
two-month period of vagal stimulation on left ventricle structure & function and inflammatory mediators in
the myocardium. Results of this study will inform stimulation protocols for current VNS systems by
assessing the therapeutic contribution of cholinergic and glutamatergic axonal subsets in heart failure
treatment.

Public health relevance
Project Narrative The current project will study the impact of selective vagal neuromodulation in a heart failure model on left ventricle structure & function indices and inflammatory mediators in the myocardium. Results of this study will inform stimulation protocols for current vagus nerve stimulation (VNS) systems by assessing the therapeutic contribution of selective axonal subsets in heart failure treatment.